TELE-TOC: Telehealth Education Leveraging Electronic Transitions Of Care for COPD Patients - Resubmission - 1

PROJECT ABSTRACT
Transitions of Care (TOC) for high-risk, frequently hospitalized adults with chronic diseases are complex, costly,
and vulnerable to safety threats and poor health outcomes. Communication breakdowns, information lapses,
and IT-induced unintended consequences can result in poor follow-up and medication non-adherence, both of
which contribute to preventable readmissions or emergency room (ER) visits. The Transitional Care Model
(TCM) aims to reduce such risks through a holistic, collaborative, patient-centered approach with in-home
interventions. Prior to the SARS-CoV-2 pandemic and resulting coronavirus disease 2019 (COVID-19), most in-
home interventions relied on in-person visits, which can be cost-prohibitive and unsustainable. One potential
sustainable and scalable solution is to use telehealth for in-home virtual visits; however, use of telehealth for
post-discharge TOC interventions has not been routinely implemented. In the post-COVID-19 era, given the
rapid expansion of telehealth, hospitals are well-positioned to initiate this virtual care. In-home virtual visits may
be particularly promising for patients with chronic obstructive pulmonary disease (COPD), who are often
hospitalized, have multiple comorbidities, and require intensive medication teaching due to rampant inhaler
misuse. COPD affects more than 16 million US adults, many of whom are older, contribute ~$50 billion to
healthcare costs annually, experience high rates of acute care revisits, often due to care coordination failures.
For this reason, Medicare’s Hospital Readmission Reduction Program (HRRP) aims to incentivize hospitals to
implement TOC programs for increased quality and value of care for COPD patients. However, currently, such
programs fall short of aligning with the full TCM. In-home interventions may be particularly salient for improving
medication skills and outcomes for patients with COPD given rampant inhaler misuses, the effectiveness of in-
hospital inhaler education, and evidence showing the need for inhaler education reinforcement post discharge.
Thus, our trans-disciplinary team proposes to implement and evaluate “TELE-TOC: Telehealth Education:
Leveraging Electronic Transitions Of Care for COPD patients,” which seeks to integrate virtual, pharmacy-based,
in-home visits for COPD patients within our hospital’s existing COPD HRRP. Our central hypotheses are that
virtual visits with pharmacists will be feasible to implement and will result in improved medication use and
outcomes among COPD patients at high risk for readmission. We aim to iteratively design TELE-TOC using
participatory study design and stakeholder input. We will then test the effectiveness of adding TELE-TOC virtual
visits in a randomized controlled trial among COPD patients enrolled in our HRRP program. Lastly, we will
develop a plan for a dissemination strategy and roadmap with national stakeholders to facilitate widescale
adoption of TELE-TOC nationwide.

Public health relevance
PROJECT NARRATIVE Transitions of Care (TOC) between hospital, ambulatory, and home settings for high-risk, frequently hospitalized adults with chronic diseases, such as chronic obstructive pulmonary disease (COPD) are complex, costly, and vulnerable to safety threats and poor health outcomes. One potential solution to address this gap in care is the Transitional Care Model (TCM), which utilizes a patient-centered approach with in-home interventions; since in- person in-home visits are costly, using innovative telehealth, such as virtual visits via teleconferencing may be just as effective with greater feasibility, scalability, and sustainability, particularly in the post-COVID-19 era as we’ve seen the rapid expansion of these technologies. With our transdisciplinary team of experts from cognitive science, care transitions/handoffs, human factors engineering, design, implementation science, and health services research, we propose to implement and evaluate “TELE-TOC: Telehealth Education: Leveraging Electronic Transitions Of Care for COPD patients,” which includes a virtual visit, pharmacy-based, in-home intervention for COPD patients to improve medication use and patient outcomes among a population at high risk for readmission and medication safety events.